PHARMACODYNAMIC AND CLINICAL EFFECTS OF NEUROLEPTICS ON FALL RISK

This study attempts to find correlations between pharmacodynamics and clinical effects of thioridazine and haloperidol on sway, reaction time, and orthostasis in three age groups (20-90 yrs).